Mitochondrial Imaging, PTM Analysis & Metabolism Core

ABSTRACT
The goal of the Mitochondrial Imaging, PTM analysis, and Metabolism Core (Core B) is to provide a high-quality
state-of-the art service to support analyses in all three of the PPG Projects. In this context, Core B will be defined
by providing four services. 1) High-resolution imaging and functional characterization of mitochondria. This will
include analyses of specific protein redistribution to mitochondria, mitochondrial network remodeling, and
markers of mitochondrial function (mitochondrial-derived reactive oxygen species, mitochondrial membrane
potential, carnitine metabolites, ATP levels). 2) Bioenergetics: oxygen consumption, rate of glycolysis, fatty acid
oxidation, measurement of cellular ATP kinetics, ETC complex analyses. 3) The analysis of protein PTMs in
biological samples. Individual proteins will be purified to assay PTMs in vivo. To analyze PTMs, we will utilize a
mass spectrometry approach coupled to the detection and quantification of specific sites of modification by
tandem mass spectrometry. 4) Metabolomic analyses. Individual metabolites in cultured cells, lung tissue, and
plasma from animals and children born with congenital heart disease that result in changes in pulmonary blood
flow (PBF). In addition, directional metabolomic flux analysis will be performed to understand the dyanimics of
metabolic pathways. Core B will enhance the scientific work for all three projects by assuring that all
mitochondrial, PTM, and metabolomic analyses are standardized and performed in a uniform standardized
manner, and by highly experienced and trained personnel. Core B is run by experienced investigators who have
had many years of experience using these techniques. They have developed or adapted many of these
techniques and applied them to perform physiological studies in vitro and in vivo systems. As a central dedicated
analytical resource, Core B will ensure these analyses are carried out in a cost-efficient manner.

Public health relevance
RELEVANCE: High-resolution imaging of the mitochondria, analyses of cell metabolism and PTMs as well as cell, tissue, and plasma metabolites are integral to the success of each of the PPG Projects. These services are best centralized given their inherent difficulty, reliance on specialized and sophisticated equipment and expertise, as well as the requirements of all three projects. Core B will provide these services for all three projects.